Studies on Inherited Chromosomally Integrated HHV-6 with Patient-derived Induced Pluripotent Stem Cells

Project Summary
Human herpesvirus 6A and human herpesvirus 6B, collectively termed HHV-6A/B, are ubiquitous viruses that
permanently infect most humans from an early age. Initial HHV-6A/B infection mainly occurs from the contact of
infected saliva or nasal mucus with the respiratory tract. However, HHV-6A/B genome can be maintained
generation to generation through inheritance, which is mediated by the integration of HHV-6A/B genomes into
the telomeres of host cell chromosomes. Inherited chromosomally integrated human herpesvirus 6 (iciHHV-6) is
seen in 1-2% of European and US populations and 0.6% of people in Japan. In these human populations, the
HHV-6 genome is integrated into the telomere of a single chromosome in every nucleated cell in the body. These
integrated viruses reactivate from the integrated chromosome to produce viral progenies. Reactivation of iciHHV-
6 is suggested to be associated with many disease developments that include encephalitis, spontaneous
abortions, pre-eclampsia, angina pectoris, and exacerbation of graft-versus-host disease following
hematopoietic stem cell transplantation. Accumulating evidence has also suggested the neurovirulence of HHV-
6A/B infection with several important neurological disorders. In particular, evidence indicates that HHV-6B
reactivation can cause acute limbic encephalitis in immunocompromised patients, and frequent viral reactivation
cycles result in temporal lobe epilepsy. However, a lack of suitable in vitro models to evaluate HHV-6A/B
reactivation from the integrated viral genome in neural cells, limits our study designs. This is because, for
diseases of the central nervous system, the affected tissue is challenging to access for study in living patients.
Such in vitro tissue culture models will examine risks of harboring iciHHV-6 in disease developments and
facilitate molecular analysis of iciHHV-6 reactivation/replication from integrated host chromosomes. Like other
virology research, establishing an in vitro culture model is vital to identify essential cellular or viral targets for
further therapeutic development. Here, we request funding to establish cell models to study iciHHV-6
reactivation. We will generate induced pluripotent stem cells (iPSCs) and differentiate them into neural stem
cells. With the established resources, we will examine how and when iciHHV-6 reactivation is triggered. We will
test what physiological cell differentiation processes trigger iciHHV-6 reactivation. We will complete the tasks
with ongoing international collaboration, and develop essential resources for HHV-6A/B researchers.

Public health relevance
Project Narrative Inherited chromosomally integrated human herpesvirus 6 (iciHHV-6) is seen in 1-2% of European and US populations, and 0.6% of populations in Japan. Currently, there are no in vitro tissue culture models that capture naturally occurring iciHHV-6 reactivation and that is important to understand the biology and pathology of iciHHV- 6. Here, we generate iciHHV-6 patient-derived induced pluripotent stem cells and utilize them to explore the molecular mechanisms of iciHHV-6 reactivation from integrated genome.